Impact of Registry Use on Quality and Outcomes in Rheumatology (QORA)

PROJECT SUMMARY / ABSTRACT
The American College of Rheumatology launched the RISE registry in 2014. RISE is a federally Qualified
Clinical Data Registry (QCDR) that passively collects data from the EHRs of participating providers,
aggregates and analyzes data centrally and continuously feeds back performance on quality measures to
practices via a web-based dashboard. RISE has grown into one of the largest rheumatology registries in the
world, with 2 million patients with 20 million encounters. However, research is needed to quantify RISE's
impact on quality and outcomes and to explore the specific mechanisms by which its health IT infrastructure
influences clinical practice. The proposed study will employ a mixed methods approach to examine variations
in use of the RISE registry web-based dashboard and explore the consequences of this variation on quality of
care and clinical outcomes. We will focus on rheumatoid arthritis (RA), the most common inflammatory arthritis
affecting 1.3 million Americans, and an area with several nationally-endorsed quality measures. Our central
hypothesis is that participation and active engagement with the data and tools available on the RISE
dashboard leads to improvements in quality and outcomes over time. The proposed Impact of Registry Use
on Quality and Outcomes in Rheumatology (QORA) project aims include 1) analyzing physician and
practice-level variation in patterns of RISE dashboard use by analyzing the extensive audit-log data in the
RISE data warehouse; 2) investigating the impact of participation and engagement with the RISE registry on
quality of care and clinical outcomes, and 3) identifying strategies for redesigning tools available on the RISE
dashboard to improve its usability and its effectiveness for local quality improvement. For this last aim, we will
perform a series of semi-structured interviews and field observations with users of RISE in different
rheumatology practice settings and work with a team of human-centered design experts. The proposed work
will allow us to generate evidence to improve RISE and maximize its impact on quality of care and outcomes
for people with rheumatic diseases. The study will also generate data to support a core public health priority for
NIAMS: improving the quality of rheumatologic care delivery in the U.S.

Public health relevance
PROJECT NARRATIVE The RISE national patient registry has broken new ground in connecting rheumatology practices around the country in a large data network, measuring quality, and providing continuous feedback on clinical performance. The proposed study will generate scientific evidence to establish the impact of RISE on clinical outcomes, while at the same time helping us understand the mechanisms of its impact through the in-depth study of registry dashboard use patterns and qualitative studies with stakeholders. Data generated through this research will inform improvements to RISE that maximize its impact on health outcomes for people with rheumatic diseases.